Developmental Programming of the Human Hypothalamus and its Role in Motivated Behaviors

ABSTRACT
This application, submitted in response to NIH PAR-19-162 “Accelerating the Pace of Child Health Research
Using Existing Data from the Adolescent Brain Cognitive Development (ABCD) Study”, aims to probe the devel-
opmental origins of mental illness, a current public health crisis. This proposal will focus on the developing hy-
pothalamus, a historically understudied region of the brain responsible for integrating the brain and bodily states.
Specifically, this proposal will test the hypothesis that the structure and connectivity of the hypothalamus is im-
pacted by early life adversity, and contributes to maladaptive brain function and behaviors underlying mental
illness. The hypothesis is tested via three independent and innovative aims capitalizing on large-scale archival
datasets from representative samples of ~11,000 adolescents from the Adolescent Brain Cognitive Development
(ABCD, 9-15 years old) study and up to 7,500 children from the HEALthy Brain and Child Development (HBCD,
0-4 years old) study. Specifically, Aim 1 will develop normative MRI-based measures of hypothalamic size and
shape, and structural and functional connectivity from birth until adulthood using two additional large-scale ar-
chival datasets from the Human Connectome Project (HCP-Development, n~1,300, 5-21 years old; HCP-Young
Adult, n~1,200, 22-35 years old) and cutting edge analytical methods. Aim 2 will assess the impact of early life
adversity (e.g., economic hardship and adverse childhood experiences) on the structure and function of the
developing hypothalamus. Aim 3 will elucidate the contribution of the structure and function of the developing
hypothalamus to the motivated behaviors (i.e., reward and inhibition) emerging during adolescence that typically
underly complex disorders and mental illness. Collectively, this proposal will capitalize on large-scale archival
datasets from representative samples to discover understudied brain-body connections and potentially provide
the basis for the subsequent development of strategies and policies aimed at mitigating the risk for mental health
disorders.

Public health relevance
PROJECT NARRATIVE This proposal describes a comprehensive plan to conduct research in a large representative developmental sam- ple to establish normative MRI-based measures of hypothalamic brain circuits, identify their susceptibility to early life adversity/stress, and determine the association of these measures with the motivated behaviors that underly several common mental health disorders. The identification of hypothalamus-related biomarkers of motivated behaviors in the context of development will contribute to an improved understanding of the neurological underpinnings of mental health risk, and identify intervention targets for primary prevention while informing policy at the national level.